Formative Implementation Research on Translating Evidence to Hospital Care for People Living With Sickle Cell Disease (FIRES)

PROJECT SUMMARY
This is an application for a K23 Mentored Career Development Award for Dr. Ashley Jenkins, a dually trained
Internal Medicine and Pediatrics (Med-Peds) hospitalist. Dr. Jenkins career goal is to become an independent
researcher who uses patient-engaged approaches and implementation science to improve hospital care and
promote health equity for patients with sickle cell disease (SCD). Over 100,000 people in the US live with SCD,
the majority of whom are people of color and living in poverty. People with SCD experience extremely painful
vaso-occlusive episodes (VOE). VOE can be fatal, yet patients avoid hospitalization for severe VOE for the
same reasons they avoid ED visits: clinicians lack SCD knowledge, disease stigma, racial bias, and
complications of health system complexity like long wait times. Care delays for severe VOE add to the risk of
death. Hence, improving VOE inpatient care may not only mitigate negative healthcare experiences for
patients with SCD, but also decrease their risk of death. The NHLBI recommends use of patient-specific
protocols, or individualized care plans (ICPs), for acute VOE care. ICPs include patient-specific
recommendations for VOE care like pain medications. When tested in the ED setting, ICPs resulted in
improved patient experience and reduced need for hospitalization. Yet, a critical knowledge gap remains
regarding how to adapt and implement ICPs tested in the emergency department for inpatient care settings.
The overall objective of this K23 proposal is to use implementation strategies to adapt and preliminarily test an
ICP prototype specific for inpatient VOE care. In Aim 1, Dr. Jenkins will develop an ICP prototype adapted from
the emergency department setting for inpatient SCD care with a patient-inclusive multistakeholder team. In Aim
2, she will test the feasibility of implementing and evaluating ICPs for inpatient VOE care at both a community
and university-based hospital. Dr. Jenkins’s career development plan includes formal coursework, intensive
mentorship, and experiential training in 1) implementation research, 2) intervention adaptation, 3) delivering
high quality SCD inpatient care, and 4) the successful conduct of multisite collaborative research. Dr. Jenkins
will be supported by the extensive resources of the University of Rochester Medical Center and Clinical and
Translational Science Institute. She has also identified expert mentors in these disciplines with outstanding
track records in training independent investigators and securing protected time for this work. This award
addresses a significant gap in SCD and hospital-based research while affording the education and mentored
research experience critical to Dr. Jenkins and her career goal of becoming an independently funded
physician-scientist.

Public health relevance
PROJECT NARRATIVE Guidelines recommend use of individualized care plans (ICPs) as an important tool for improving sickle cell disease (SCD) care quality based on data from the emergency department. However, literature addressing ICP use for inpatient care is sparse and we do not know the best way to use ICPs for hospitalized patients with SCD. This proposal will engage adults with SCD and healthcare team members in 1) adapting ICPs from the emergency department to the inpatient care setting and 2) testing the feasibility of using ICPs for inpatient SCD care.